CLINICAL ASSESSMENT OF MATURATION--NEW STRATEGIES TO MATURE THE PRETERM FETUS

To determine effects in newborns of antenatal maternal glucocorticoids alone or in combination with TRH. To utilize tissues to evaluate maturational processes and to institute a clinical trial of a new fetal maturation strategy.